Xavier RCMI Renewal Application-Administrative Core

RCMI Administrative Core Summary
The RCMI Cancer Research Center at Xavier University will provide a critical platform for researchers of
diverse training and expertise to effectively address racial disparities with a focus on cancer biology, cancer
prevention, diagnosis, treatment and clinical outcome. The overarching goal of the RCMI Program at Xavier
University is to enhance biomedical research capacity in minority health and health disparities. To reach this
goal, we plan to enhance faculty and programmatic research competitiveness, especially in the areas of
cancer, minority health disparities and translational research. The Administrative Core will function as the
managing unit of Xavier's RCMI program by providing leadership and creating a collaborative infrastructure
that manages, coordinates, integrates, and supports the scope of the RCMI program activities. The
Administrative Core will promote and facilitate integrated communications within and across the Investigator
Development, Resource Infrastructure and Community Engagement Cores and the three proposed research
projects. The Administrative Core will also be responsible for evaluating the progress of each research project
and all cores to ensure each evaluation metrics of the RCMI program are met. The Administrative Core will
effectively manage the RCMI Program by achieving five specific aims. Aim 1. Provide effective leadership in
managing the key RCMI activities. The Admin Core leadership team will consist of PIs, Core Directors, and
Program Managers, have monthly meetings to review progress, identify problems, discuss and implement
solutions and improvement plans to ensure that each program goal is achieved as measured by assessment
milestones. Aim 2. To implement processes for efficient use of the research infrastructure core facilities. The
Administrative Core will have monthly standing meetings with the core faculty expertise group to review core
operations, policies and procedures. Quarterly core service surveys and quarterly core service reports will be
collected which track user satisfaction, core efficiency, and outcomes as measured by core-citing publications
and grant applications with core participation. Aim 3. To provide administrative assistance in developing
successful grant proposals for external support. The Admin Core will work collaboratively with Xavier's Office
of Research and Sponsored Programs (ORSP) to assist faculty and staff in obtaining external grants and
contracts, including identifying potential sources of funding, providing professional review of proposals prior to
submission, and assisting faculty in the administration of their grants. The RCMI will organize seminars and
grant writing workshops jointly with ORSP and provide financial and logistic support to a network of mentors for
pilot projects and junior investigators in developing grantsmanship. Aim 4. To promote and facilitate the
development of a diverse pool of investigators actively engaged in research on minority health and health
disparity diseases, and in community-based behavioral research. The Investigator Development Core will
support early stage investigators in conducting basic biomedical research related to cancer and health
disparities as well as community-based health disparity research but who have not received independent
funding from external sources such as NIH. Aim 5. To implement the RCMI Program evaluation plan by
coordinating with the RCMI Advisory Committee, the CEC Community Advisory Board, and the Independent
Evaluator. The Administrative Core will coordinate and oversee the comprehensive evaluation of the RCMI
program in enhancing the institutional infrastructure and environment necessary to facilitate biomedical
research in cancer and cancer related health disparities, increasing productivity of investigators in peer-
reviewed publications and discovery, and increasing the Xavier investigators' overall success in securing
extramural research funding. In addition, the Administrative Core will organize RCMI-wide meetings and
conferences, including meetings of the Advisory Committee and pilot project review sessions. The Admin Core
will also be responsible for ensuring compliance of all RCMI research activities with IRB and IACUC and other
federal, state, and local regulations.